LYMPHOCYTE B-ADRENERGIC RECEPTORS IN MULTIPLE SCLEROSIS

This project will prospectively test the hypothesis that altered beta-adrenergic receptor activity contributes to the abnormal immunoregulation seen in multiple sclerosis.